Scheduled Prophylactic 6-hourly IV Acetaminophen to Prevent Postoperative Delirium in Older Cardiac Surgical Patients (PANDORA) - EEG Administrative Supplement

Project Summary / Abstract
The parent project’s objective is to find an effective prophylactic intervention for postoperative delirium, one of
the most common and detrimental complications of cardiac surgery in older adults. The central hypothesis of
this proposal is that scheduled prophylactic 6-hourly IV acetaminophen can prevent postoperative delirium in
older cardiac surgical patients when administered in the first 48 hours following surgery.
The rationale underlying this proposal is that while multiple etiological factors exist for the development of
delirium, modifiable risk factors include inflammation, undertreated pain, and use of opioids. Each of these is
an independent risk factor for delirium that is amenable to intervention with use of IV acetaminophen. Through
this straightforward intervention, it is possible to use a highly prevalent, non-toxic medication to address a well-
known problem. We propose three specific aims by conducting a randomized, triple blind clinical trial that
enrolls 900 patients 60 years of age or older undergoing cardiac surgery. Through this trial, we will determine
the effect of IV acetaminophen on; 1) the incidence, duration, and severity of postoperative delirium, 2) the use
of opioids and other rescue analgesics in the first 48 postoperative hours, daily pain scores at rest and
exertion, and length of stay in the Intensive Care Unit and overall hospital length of stay 3) longer-term (one,
six, 12 months) cognitive,physical, and self-care functional recovery after surgery. We will pursue these aims
using an innovative method of administering a routine drug intravenously in scheduled, six hourly intervals for
48 hours, which is the period of maximum secondary injury, inflammation, and pain postoperatively. The
proposed research is significant because it will determine whether targeting inflammation and pain through a
multimodal analgesic approach can reduce the incidence of postoperative delirium in a vulnerable, aging
population. The expected outcome of this work, which will be interesting regardless of the findings, will be
to determine the role of IV acetaminophen in the prevention of delirium, and in pain management for older
cardiac surgery patients. The results will have an important positive impact as they will facilitate either
widespread adoption of IV acetaminophen as a pain control modality for older adults undergoing major
surgery, or to provide strong evidence to eliminate its use if it is proven to be ineffective. Additionally, we will
further our understanding of the association between pain management modalities and delirium, and other
important short and long term outcomes of older adults undergoing cardiac surgery.
Supplement Aim 1: To create a large, multi-site database of EEG recordings obtained during cardiac
surgery to be harvested for offline analysis of EEG biomarkers.
Supplement Aim 2: To identify pre/intra/postoperative EEG biomarkers that can be useful in predicting
POD in cardiac surgery patients.
Supplement Aim 3: To explore whether EEG biomarkers for POD interact with IV administration of
acetaminophen.
IMPACT: This application requests funds to acquire a large database of EEG data recorded during cardiac
surgery. EEG is an important index of patient state during anesthesia and surgery and a rich source of data
from which biomarkers can be developed to predict postoperative delirium in cardiac surgery. Furthermore,
once we identify EEG signatures consistent with POD developed, we can test how they interact with IV
administration of acetaminophen. The proposed supplementary aims thus augment the significance and
innovation of the parent project and are congruent with the efforts of the NIH to enhance scientific rigor and
generalizability in clinical research.

Public health relevance
Delirium following cardiac surgery is debilitating in both the short and long term. Pain following surgery is a leading precipitating cause of delirium. In this randomized study done in multiple centers, simple and effective pain relief with intravenous acetaminophen over 48 hours can reduce use of opioids and give effective pain relief that could ultimately reduce delirium in a wide racial and ethnic distribution of patients. In the supplement, a large intraoperative database of EEG recordings will be created and explored to identify EEG signatures of postoperative delirium.